The Oklahoma Pediatric Clinical Trials Network

PROJECT SUMMARY/ABSTRACT
The goal of the Oklahoma Pediatric Clinical Trials Network (OPCTN) is to provide access for the
underserved rural, urban minority, and American Indian populations of children in Oklahoma to state-of-the-art
clinical trials and the transfer of findings that will benefit the health of those children. The OPCTN will continue
to be a member of the Environmental influences on Child Health Outcomes (ECHO) IDeA States Pediatric
Clinical Trials Network (ISPCTN). The ISPCTN facilitates involvement of sites in IDeA states to design and
implement clinical trials related to the 5 primary ECHO focus areas: 1) upper and lower airway disease, 2)
obesity; 3) pre-, peri-, and postnatal outcomes; 4) neurodevelopment; and 5) positive child health. These are
each areas of substantial health concern for Oklahoma, where our overall child health is rated amongst the
worst in the United States.
The first phase of OPCTN was successful in developing capacity for pediatric clinical trials through
mentoring of junior clinical investigators, building clinical informatics resources, leadership with the ISPCTN
network, and participation ISPCTN-led trials. The OPCTN was consistently among the top three recruiting sites
within the network and led the development of an ISPCTN feasibility trial focused on rural populations.
For this renewal phase of the OPCTN, we have assembled a diverse mixture of resources within Oklahoma.
It is centered in the Department of Pediatrics and the Oklahoma Clinical and Translational Science Institute at
the University of Oklahoma Health Sciences Center. It combines the resources of Oklahoma’s IDeA-CTR, the
Oklahoma Shared Clinical and Translational Resources, academic physicians at the state’s allopathic medical
school, clinical trials experts at the Stephenson Cancer Center, providers in Oklahoma urban and rural
communities, and practice-based research networks in order to broaden the opportunities for children in
Oklahoma to participate in clinical research studies. The OPCTN engages with community consultant groups
that represent the American Indian, Latino, and African American communities as well as county-based health
improvement organizations within the state to allow their input on research project design, implementation, and
community participatory interest. The OPCTN also focuses on training pediatric clinicians and research staff to
enhance their experience in the design and conduct of clinical trials in order to increase the capacity of the
medical community in the state to conduct clinical and translational research efforts.

Public health relevance
PROJECT NARRATIVE We propose the continuation of the Oklahoma Pediatric Clinical Trials Network (OPCTN) as a site in the Environmental influences on Child Health Outcomes (ECHO) IDeA States Pediatric Clinical Trials Network (ISPCTN). The goal of the OPCTN is to provide access for the under-represented and rural populations of children in Oklahoma to state-of-the-art clinical trials and the transfer of findings that will benefit the health of those children. We will accomplish this goal by utilizing the OPCTN infrastructure to enhance capacity by providing opportunities for clinically trained junior faculty to gain experience in the conduct of clinical trials, utilizing ISPCTN trials to provide access for Oklahoma’s children, and providing support to the ISPCTN network through engagement in the development and implementation of clinical trials designed to emphasize participation by our population.